LEAD OPTIMIZATION OF A LONG NON-CODING RNA (LNCRNA) AS A POTENTIAL LIPID- AND GLUCOSE-LOWERING THERAPEUTIC

The contractor(s) will be responsible to perform synthesis of lead RNA candidates, conducting potency
assay development to optimize and downslect RNA leads, to conduct exploratory toxicity studies and
DMPK to assess the safety of the leads, and in vivo efficacy studies as a go/no go miletone.